Computer Modeling of G Protein-Coupled Receptors

Extracellular purines and pyrimidines bind to several families of transmembrane-spanning (7TM) receptors. These receptors are G protein-coupled receptors of the Group A rhodopsin-like family, which includes many important targets for pharmaceutical development. [unreadable] [unreadable] We have applied mutagenesis and rhodopsin-based homology modeling to the study of purine and pyrimidine receptors and used the structural insights gained to assist in the design of novel ligands. Because crystallographic structural determination of nearly all 7TM receptors is not yet feasible, we achieved the structure-function analysis of adenosine and P2Y receptors by indirect means, using mutagenesis and homology modeling, based on a template of the high-resolution structure of rhodopsin. 3D homology models of the human A2A (1UPE), A3 (1OEA), P2Y1 (1Y36), P2Y2 (1Z8E), P2Y6 (2B6R) and P2Y12 (1Y9C) receptors from our laboratory and others have been deposited in the RCSB Protein Data Bank (Rutgers, The State University of New Jersey, USA). [unreadable] [unreadable] The nucleotide receptors, denoted P2, comprise both ligand-gated ion channels (seven subtypes of P2X receptors) and 7TM receptors (eight subtypes of P2Y receptors). The distribution of P2Y receptors is broad, and the therapeutic interests include antithrombotic therapy, modulation of the immune system and cardiovascular system, and treatment of cystic fibrosis and other pulmonary diseases. There are two subgroups of P2Y receptors, containing different sets of cationic residues for coordinating the phosphate groups. The two subgroups have been defined based on clustering of sequences (in general, low similarity among subtypes), ligand preference, second messenger coupling, and receptor sequence analysis. The P2Y1, P2Y2, P2Y4, P2Y6, and P2Y11 receptors couple preferentially to the stimulation of phospholipase C-beta, and the P2Y12, P2Y13, and P2Y14 receptors couple preferentially to the inhibition of adenylate cyclase. P2Y1 and P2Y12 receptors occur on the surface of platelets and both act in concert to promote aggregation in response to ADP, and consequently, their antagonists are of interest as antiplatelet agents. [unreadable] [unreadable] We used molecular modeling based on a rhodopsin template in conjunction with mutagenesis to identify recognition elements important for nucleotide binding at the P2Y1 and other P2Y receptors. In order to ascertain which residues of the P2Y1 receptor were involved in ligand recognition and activation, individual residues of the TMs (3, 5, 6, and 7) and ELs 2 and 3 were mutated to Ala and various charged residues. A cluster of positively charged lysine and arginine residues near the exofacial side of TMs 3, 6 and 7 putatively coordinate the phosphate moieties of nucleotide agonists and antagonists. The two subgroups of P2Y receptors (either P2Y1like or P2Y12like) contain different sets of cationic residues that function in the coordination of the 5-di- or triphosphate groups. At the P2Y1 receptor, it has been possible to convert nucleotide agonists (5-diphosphate derivatives) into antagonists by separating the diphosphate moiety into bisphophates attached at the 3 and 5 positions, or alternately at the 2 and 5 positions. Based on structure activity relationship (SAR) studies, there is a small hydrophobic pocket present at the N6 binding region of the P2Y1 receptor. [unreadable] [unreadable] The native ligands for the most recently cloned member of the P2Y receptor family, the P2Y14 receptor, are UDP-sugars, such as UDP-glucose. This receptor is involved in immune function. We have modeled the P2Y14 receptor by homology to rhodopsin and docked various nucleotide ligands. Compared to other P2Y receptors, the P2Y14 receptor has an atypical binding mode of the nucleobase, ribose and phosphate moieties. The ligand binding modes obtained in this study demonstrated that two key cationic residues, namely Arg6.55 and Lys7.35, together with two anionic residues (Glu166 and Glu174 located in EL2), can interact with the hexose moiety. A third conserved key cationic residue, namely Lys171, interacts with the -phosphate group of the ligand. The lower activity of 4 and its receptor docking suggest limited steric tolerance at the 2 position of the hexose moiety[unreadable] [unreadable] ARs are involved in many of the bodys cytoprotective functions. Modelingmutagenesis of adenosine receptors has focused on determinants of binding of nucleoside and nonnucleoside heterocyclic derivatives and also on determinants of the intrinsic efficacy in adenosine derivatives and on amino acid residues involved in the activation process. It should be noted that the only current crystallographic structures of rhodopsin to serve as a template for 7TM receptor structure are of the inactive (resting) state, which is more applicable to modeling antagonist docking. However, the model has prooven useful for studying agonist ligands as well, and has helped to elucidate which local conformational changes may be involved in activation of the receptor. For example, for docking of NECA and other agonists to the A3AR model, binding in the region of the 5-substituent induced a movement of the side-chain of W243 (6.48). This conserved aromatic residue has been described as a rotamer switch for activation of a variety of 7TM receptors, including the beta-adrenergic receptor, A3AR, and P2Y1 receptors. Its mutation to Ala in all of the latter (purinergic) subtypes has been shown to preclude activation of the receptor by agonist but not binding of the same ligands.